Biophysical regulation of intercellular communication by the glycocalyx

Project Summary/Abstract
In a multicellular organism, every decision and action taken by a cell depends on communication with its
neighbors. Lethal diseases, such as cancer, can arise when normal communication channels are disrupted. In
this proposal, we investigate two specialized communication protocols that serve in the exchange of complex
information packets between participating cells. In the first type, cells package proteins and genetic material into
tiny, membrane-encapsulated containers, called vesicles, for delivery to recipient cells. In the second protocol,
cells extend long and thin membrane tubules that form highways between participating cells for free or regulated
exchange of cellular contents. Our central hypothesis is that these two important forms of intercellular
communication are regulated by sugary polymers that cells assemble on their outer membrane. Like a
compressed gas hovering over the cells, we propose that these sugary polymers can generate a pressure that
makes it easier to bend the membrane into the spherical and tubular forms required for vesicles and intercellular
highways. Thus, we anticipate that cells can ramp up communication by assembling more sugary polymers on
the cell surface, or, conversely, suppress communication through a reduction of cell-surface polymers. In this
proposal, our aims are to (1) determine how and what type of information is exchanged through the membrane
bridges; (2) identify how the formation of the membrane bridges are controlled by the internal cellular skeleton
and its regulators; and (3) determine the optimal conditions for vesicle generation and transfer of messages to
participating cells.
To study these possibilities, we will use sophisticated new imaging techniques capable of resolving ultrasmall
cellular features, like the membrane structures that are under investigation here. We also take advantage of our
ability to create DNA instruction sets that can program cells to assemble new and different polymer types on
their outer membrane. A major goal is to identify the types of messages that are sent from donor to receiver
cells. In addition to advanced imaging approaches, we will use powerful, “next-generation” techniques that can
simultaneously identify large numbers of proteins or nucleic acids (i.e. genetic instructions), which may be part
of the messages transferred.
The new understanding that we seek to develop should have broad relevance in biomedicine. In particular,
aggressive cancer cells often produce and attach unusual numbers of sugary polymers on their outer membrane.
Thus, our studies could provide new insight into how intercellular communication goes awry in cancer, and how
we might intervene therapeutically to normalize and correct the flow of information among our cells.

Public health relevance
Project Narrative Cells send important messages to each other through long finger-like extensions or by packaging information into tiny containers, called vesicles, that bud off from the cell surface. The information delivered by these means is essential for the proper functioning of our tissues and can contribute to diseases, such as cancer, when the messages are compromised. Here, we investigate how the glycocalyx, a natural material coating on the surface of each of our cells, can control cell-to-cell messaging through finger-like extensions and vesicles in hopes of better understanding the requirements for healthy intercellular communication.